Mechanisms of Biological Fluoride Resistance Exporters

Project summary This project will subject two newly discovered families of F- -transporting membrane proteins to detailed functional and mechanistic scrutiny and will seek to solve their high-resolution crystal structures. These proteins expel F- from the cytoplasm to protect bacteria and unicellular eukaryotes from the toxic effects of ambient F- in the environment. The two protein families are phylogenetically unrelated. The CLCF exporters represent a clade within the long-studied CLC superfamily of anion channels and transporters, while the Fluc exporters are a previously unknown-function family of small membrane proteins. Our preliminary experiments have already uncovered for the CLCF exporters several surprising variations on mechanistic themes well-established for Cl- transport in conventional CLC proteins: (1) the absence of the anion- coordinating residues conserved among all previously studied CLCs, (2) an extremely high selectivity for F-, (3) a proton-coupled F- antiport mechanism despite a signature sequence suggesting that these would be ion channels, and (4) an unprecedented 1-to-1 anion/H+ exchange stoichiometry. For Fluc proteins, our work shows these to be highly F--selective ion channels. Sequence analysis argues strongly that the functional channel is an unusual antiparallel oligomer, and our experimental results indicate unprecedented dimeric architecture in which the twin subunits are inserted into the membrane in opposite orientations. The project combines electrophysiological, membrane-biophysical, and structural analysis to attack fundamental questions arising from these results: what residues determine anion- selectivity and H+ movement in the CLCF antiporters? How must we modify accepted antiport mechanisms to account for the surprising 1-to-1 F-/H+ stoichiometry of CLCFs? Where are the pore-lining residues in Fluc channels and what accounts for their high anion selectivity? Answers to basic questions like these are necessary to bring into focus our view of how these membrane proteins work to export F- and thus counteract this ion's pervasive challenge to cellular integrity. Since these F- exporters are found in many bacterial and eukaryotic pathogens but not in vertebrates, they may provide novel antibiotic targets.

Public health relevance
Project narrative This project is aimed at fundamental properties of a very new and unusual class of membrane proteins, and as such falls into the category of basic research. However, the fluoride exporters under study here protect many pathogenic organisms from environmental fluoride (e.g., Mycobacterium tuberculosis, Enterococcus caselliflavus, Candida albicans, Leishmania major, Toxoplasma gondii), but are not found in any vertebrate genomes. These might therefore eventually provide unique targets for novel antibiotics, since environmental F- is forever all around us and must be dealt with by unicellular microorganisms.